Mitochondrial positioning regulates redox-signaling during cell migration

PROJECT SUMMARY
Mitochondria are strategically trafficked throughout the cell by the action of adapter proteins, microtubule motors
and the actin cytoskeleton. The intracellular positioning of mitochondria supports subcellular levels of ATP, CA2+
and reactive oxygen species (ROS, i.e. hydrogen peroxide, H2O2). We have provided direct evidence that
mitochondria actively traffic into the leading edge of migrating cells to support phenotypes associated with cell
migration. Deletion of the mitochondrial adapter protein Miro1 leads to perinuclear restriction of mitochondria in
mouse embryonic fibroblasts, leaving the cell periphery devoid of mitochondria. Importantly, cells lacking Miro1
retain normal mitochondrial bioenergetics. Our laboratory has shown that deletion of Miro1 disrupts subcellular
energy gradients, focal adhesion (FA) dynamics and significantly reduces cell migration. Cell migration is
rescued when Miro1 is reintroduced into cells lacking Miro1. However, the specific signaling events supporting
cell migration that are governed by local mitochondrial populations are still unclear. Our preliminary data provides
strong evidence that mitochondrial distribution dictates subcellular H2O2 gradients and therefore perinuclear
restriction of mitochondria in cells lacking Miro1 compromises leading edge H2O2 levels. H2O2 acts as a signaling
molecule, oxidizing specific cysteine residues in target proteins, influencing protein structure and function, a
process termed redox dependent signaling. H2O2 is rapidly consumed at sites proximal to the source
(mitochondria) and therefore must be produced in close proximity to the target. We find the oxidation of key
cysteine residues in proteins driving FA dynamics and cell migration are significantly less oxidized in cells lacking
Miro1. Addition of H2O2 to the extracellular milieu partially rescues cell migration phenotypes in cells lacking
Miro1. Therefore, we hypothesize that Miro1-mediated subcellular positioning of mitochondria induces localized
redox-dependent signaling events to support cytoskeleton and FA dynamics. We will test this hypothesis by
generating a spatial and temporal map of subcellular H2O2 levels dependent on Miro1-mediated mitochondrial
positioning in relationship to FA and cytoskeleton dynamics during cell attachment and migration. We will
investigate the importance of specific cysteine oxidation events dependent on Miro1-mediated mitochondrial
trafficking in supporting protein phosphorylation and FA and cytoskeleton dynamics. Lastly, we will investigate
how the subcellular architecture of mitochondria influences gene-expression patterns, with an emphasis on cell
migration genes. At the end of the proposed studies, we will have established a detailed mechanistic relationship
between the subcellular trafficking of mitochondria and redox-dependent signaling events governing gene
expression, protein post-translational modifications and FA and cytoskeleton dynamics during cell attachment
and migration.

Public health relevance
PROJECT NARRATIVE The inside of our cells is a complex jumble of signals that must be interpreted in space in time to regulate dynamic cell processes. To support this the signal source must be in close proximity to the desired target. The current application proposes to investigate how the distribution of mitochondria (signal source) within our cells supports protein modifications (target) required to coordinate cell attachment and movement.